International Society for Biomedical Research on Alcoholism (ISBRA)

PROJECT SUMMARY
The Congress of the International Society for Biomedical Research on Alcoholism (ISBRA) is the premier
international scientific meeting devoted to alcohol research. Alcohol use and misuse is the leading risk factor
for attributable burden of disease among people ages 25 to 49 and the 7th highest risk factor for premature
death and disability worldwide. Given the immense global public health and personal cost of alcohol misuse
and use disorders, it is critical to have a venue for scientific exchange among international researchers to
address important research questions that inform public health policies, prevention and treatment strategies.
The ISBRA Congress brings together an international cadre of alcohol researchers that study the biomedical,
psychosocial, and clinical aspects of alcohol use, misuse and addiction. During this Congress, basic and
clinical scientists provide updates on scientific findings, exchange ideas, discuss and debate issues in the field,
and form scientific collaborations. This scientific exchange is invaluable for both established and developing
research programs around the world. The ISBRA Congress location is rotated among the Americas, Europe,
and Asia/Australia. The 2024 ISBRA Congress will be held on September 23-26 in Melbourne, Australia as a
joint meeting with Asia-Pacific Society for Alcohol and Addiction Research (APSAAR); the 2025 Congress will
be held in June 21-25 as a joint meeting with the Research Society on Alcohol (RSA) in New Orleans, LA,
USA. Subsequent meeting locations will rotate among Europe, Asia and then the Americas, the destination
determined by the ISBRA Board. This application would provide partial travel support for scientists to attend
these important Congresses. Funding support is prioritized to ensure that trainees, early-stage career
investigators, and scientists who would otherwise not be able to attend can participate in the conference, to
foster the growth of young and diverse scientists that will develop into the leaders of the alcohol research field.

Public health relevance
PROJECT NARRATIVE Alcohol use and misuse is the leading global risk factor for attributable burden of disease among young adults. The International Society for Biomedical Research on Alcoholism (ISBRA) is the premier international organization focused on promoting excellence in alcohol research, and ISBRA Congresses provide an important forum for discussion and collaboration among researchers focused on this serious public health problem. This grant provides support for a diverse group of trainees and early-stage investigators to participate in the conference and engage efforts to address the biomedical, psychosocial, and clinical issues related to alcohol use and misuse.